In vitro and in vivo screening of medical countermeasures directed against select viruses

To expand capacity for in vivo testing of candidate antivirals directed against viruses with the potential to cause outbreaks.